NCANDA: Data Analysis Resource

Excessive alcohol drinking Initiated during adolescence is known to disturb typical
neurodevelopmental patterns, increase the risk of developing alcohol use disorder (AUD),
and accelerate involutional processes in adulthood. In response to RFA-AA-21-009, the
Data Analysis Resource (DAR) proposes to support the next 5 years' data collection and
analysis across a community sample that were recruited in 3 age bands between 12 and
21 years old, were mostly no-to-low drinkers, and tracked over the last 8 years across 5
sites (N=831; 93% retention rate). Monitoring has involved annually-acquired
multimodal neuroimaging (MRI, DTI, resting state fMRI, task fMRI) and cognitive,
clinical, behavioral, and biological data, collected in person or remotely by computer and
our mobile app. These measures will now be complemented with new advanced
neuroimaging and sleep and physical activity tracking. This cohort sequential design
uniquely positions NCANDA-A to quantify transient or enduring alcohol-related
disturbances in specific adolescent and early adult neural system growth trajectories and
functional concomitants.
NCANDA-A proposes four consortium-wide specific aims and two specialty project
aims. In Aim 1, NCANDA-A will investigate the impact of excessive alcohol drinking
during adolescence and emerging adulthood on subsequent developmental trajectories of
cognitive performance, brain structure and function, and psychopathology. Aim 2
analyses will identify neurodevelopment patterns describing the extent to which alcohol’s
effects on brain structure and function resolve or persist during desistance after binge
drinking. Aim 3 will deploy data-driven analysis to identify adolescent biological,
environmental, and behavioral factors (e.g., age of drinking onset) that forecast excessive
drinking during early adulthood. In Aim 4, NCANDA-A will quantify the impact of
stressful events on social, emotional, and economic wellbeing and their relations with
alcohol use patterns. For each aim, differences in development, alcohol use patterns and
history, impact of alcohol use on the brain, and psychosocial factors will be tested.
The goal of the DAR is to support hypothesis testing based on five aims. Aim D1 will
ensure that procedures for collection and quality control of neuroimaging,
neuropsychological, and clinical assessment data are standardized. In Aim D2, the DAR
will advance the existing informatics infrastructure for integrating data collected across
all sites. Aim D3 will enhance macrostructural, microstructural, and functional
neuroimage processing and analysis. In Aim D4, the DAR will create machine (deep)
learning frameworks identifying predictive markers of early adulthood drinking. Aim D5
will maintain data sharing and distribution systems for consortium PIs and the scientific
public at large.
With the longitudinal data collected into early adulthood during this renewal, NCANDAA
will provide novel information to the public on the enduring and transient effects of
adolescent drinking on adult functioning.

Public health relevance
Heavy alcohol drinking during adolescence is known to disturb brain development and functioning and increase risk of drinking problems in adulthood, but the extent of the lingering effects of youthful drinking on adult functioning remains unclear. The goal of NCANDA-A (Adulthood) is to follow youth who have and have not engaged in hazardous drinking to determine alcohol's influence on the brain, cognition, emotion, and life activities in emerging adulthood when young adults are establishing themselves in careers, relationships, and independent living. Recognition of signs of risk to adjustment in adulthood following youthful drinking may enhance opportunity for personal success.